The effect of genetic variation on mRNA splicing in chondrocytes responding to cartilage matrix damage

Project Summary
Osteoarthritis (OA) is a prevalent joint disease that affects over 250 million individuals globally. Despite
extensive research, there are no known cures or therapies to prevent the disease's progression. Understanding
the complex molecular mechanisms responsible for its development and progression is crucial. Genome-wide
association studies (GWAS) have identified over 100 loci associated with OA disease risk; however, identifying
the putative causal variants and the affected genes has been challenging due to the non-coding nature of
most OA risk variants and the linkage disequilibrium between nearby variants.
Alternative mRNA splicing can alter transcript and protein function, and its dysregulation has been implicated
in a wide variety of human diseases. Previous studies have found differentially spliced transcripts in OA tissue,
suggesting it may play a role in OA pathogenesis; however, the genetic causes and OA-related impacts of
alternative splicing in human chondrocytes have not yet been explored.
The overall objective is to identify genetic variants that alter OA risk by influencing RNA splicing in either
resting or stimulated chondrocytes. The project will identify differential splicing events in chondrocytes
responding to cartilage matrix damage (Aim 1), identify genetic variants that influence splicing patterns (i.e.,
splicing QTLs) in both resting and activated chondrocytes (Aim 2), and integrate these results with OA GWAS
data to identify putative disease-relevant variants and genes, followed by experimental validation. (Aim 3). The
findings from this research will pave the way for developing new treatments and drug targets for OA.

Public health relevance
Project Narrative Osteoarthritis affects over 250 million people worldwide, and despite extensive research, a lack of under- standing of the molecular mechanisms underlying its risk factors has hindered the development of effective treatments. This study aims to identify novel genetic variants and splicing events that influence osteoarthritis risk by correlating genetic background, splicing patterns, and disease status. The results of this study are expected to provide new genes and pathways for future research and therapeutic development.